CANCER CENTER SUPPORT GRANT (COMPREHENSIVE)

The specific objectives of the Mayo Comprehensive Cancer Center over the next five years are the following: 1) To enhance programs of clinical cancer research with particular emphasis on continued multidisciplinary coordination and on close liaison with and involvement of laboratory scientists. 2) To improve the quality and expeditious conduct of clinical cancer research programs by establishing appropriate and cost-effective shared resources, e.g., Cancer Center Statistical Unit, Cancer Pharmacy Unit, Surgical Pathology Shared Resource. 3) To continue development of basic laboratory programs in cancer and promote a "centerness" among our laboratories by establishing appropriate shared resources, e.g., flow cytometry, protein analysis, monoclonal antibodies, immunogenetic mouse colony. 4) To continue development of laboratory research programs which are in direct affiliation with clinical research programs and which serve as a functional interface between basic scientist and clinical scientist, e.g., the cancer pharmacology laboratory, the radiation biology laboratory, the cell culture laboratory. 5) To fulfill our role as a Comprehensive Cancer Center by expanding our clinical research boundaries to involve the major community cancer centers of our region. 6) To develop new clinical and laboratory research programs which are appropriate to the assets of our Center. To continue and increase our active participation in the national cancer program.